SaefCAR: Regulatable CAR-T cells for safe and effective immunotherapy

Project Summary:
Despite the remarkable success in the treatment of some hematological cancers, the risk of serious adverse
events and loss of potency remain major problems that threaten to curtail widespread application of chimeric
antigen receptor (CAR) T-cell therapies to other cancer types including solid tumors. These problems, all of
which are influenced by the binding affinity of the CAR targeting domain, result from the propensity for
unpredictable hyperactivation that can lead to potentially fatal systemic toxicities such as cytokine release
syndrome (CRS), tumor lysis syndrome (TLS) and neurotoxicity. Furthermore, on-target off-tumor toxicities can
result from the indiscriminate binding of constitutively expressed CARs to tumor antigens on healthy tissues,
whilst disease relapses can occur due to antigen escape and/or T cell exhaustion. Current and emerging CAR-
T cell strategies and designs to address these problems are often too slow in terms of response times and onset
of action. Furthermore, they prematurely and permanently eliminate the “high value” cells and often require the
expression of additional proteins which may constrain the DNA payload capacity of current lenti- and retro- virus
vectors. There is thus an urgent unmet need for in-vivo regulatable CAR-T cell platforms that are rapid, reversible
and don’t exert a substantial DNA burden on the CAR delivery vector. The objective of this proposal is to assess
the feasibility to regulate the activation, effector functions and cytokine release of CAR T-cells using an
exogenously administered ligand that modulates the affinity of the CAR T-cell targeting domain. To this end we
will utilize our proprietary universal allosteric-linker and switch module for antibodies (UNASMA) technology to
incorporate an ON/OFF affinity switch into a well characterized antibody single chain variable fragment (scFv)
against a clinically validated hematological cancer target which will subsequently be formatted as a switchable
affinity chimeric antigen receptor (SaefCAR). We postulate that the resulting SaefCAR following transduction
into a T-cell, will enable the in-vivo regulation of the SaefCAR T-cells’ activity via exogenous administration of a
small molecule or peptide ligand, potentially solving several of the problems of current CAR-T cell therapies by:
1) Ameliorating intrinsic toxicities via enablement of a slow start to T-cell activation, 2) Preventing on-target off-
tumor toxicities by switching off the CAR-T cell without eliminating it 3) Preventing exhaustion of tumor-specific
CAR T cells caused by tonic signaling and other mechanisms via intermittent ON/OFF switching of the CAR.
Specifically in Aim 1 we will develop switchable forms of the scFv which will subsequently be formatted into a
CAR and transduced into a T-cell in Aim 2. In Aim 3 we will validate proof-of-concept of the regulated SaefCAR
T-cells in in-vitro and in-vivo studies. We aim to demonstrate that a ligand-controllable affinity switch in the
binding domain of SaefCAR T-cells can regulate it’s activation and effector functions against a tumor. Importantly
due to the universal character of our approach, it provides a blueprint to improve any scFv-based CAR T-cell
therapy in the future by adding a capability to regulate the CAR affinity for the tumor antigen.

Public health relevance
Project Narrative: The widespread application of chimeric antigen receptor (CAR) T-cell therapies to other cancer types including solid tumors is curtailed by the risk of serious adverse events and loss of potency all of which are influenced by the binding affinity of the CAR targeting domain. In this project, Mabswitch will develop switchable affinity chimeric antigen receptor (SaefCAR) T-cells based on a commercially validated CAR-T cell therapy with the aim to demonstrate the in-vivo regulatability of the CAR-T cells activation, effector function and cytokine release upon exogenous administration of a small molecule or peptide ligand that modulates the affinity of the CAR T-cell targeting domain. Importantly due to the universal character of the approach, it provides a blueprint to improve any scFv-based CAR-T cell therapy by adding a capability to regulate the CAR affinity for the tumor antigen.